Psychobiological Mechanisms Underlying the Association Between Early Life Stress and Depression Across Adolescence

Abstract
More than 50% of youth will experience at least one form of significant adversity in early life. Such
adversities pose significant risk not only for the development of psychopathology over the life course, but also
for attempted suicide, a leading cause of death in people ages 10-24 years. We have recruited and assessed
220 9- to 13-year-old boys and girls across four timepoints, each two years apart, to examine the effects of
exposure to ELS on trajectories of stress reactivity and reward sensitivity, and, in turn, their impact on the
onset of psychopathology and suicidal behaviors across adolescence. In this cohort we have conducted
repeated measurements of symptoms and diagnoses of psychopathology, neural, endocrine, cognitive,
immunological, and behavioral assessments of stress reactivity and reward sensitivity, and early exposure to
adversity, including the type, severity, and timing of stressful events. We have published a series of papers
from this project elucidating the effects of ELS on psychobiological functioning, trajectories of brain
development, and biological aging, and the consequences of these alterations for clinical functioning. In this
MERIT renewal application, we propose to build on and extend our work in three important ways. First, we will
conduct an additional assessment of our participants at age 20 in order to examine the effects of ELS on
trajectories of neurodevelopment and clinical outcomes from childhood to young adulthood, as well as the
persistence of COVID-19 pandemic-related difficulties in mental health, stress, and brain metrics. We will also
extend our examination of how environmental pollutants and conditions affect relations among these variables.
Second, we will extend and replicate our findings in a younger, non-Western sample by analyzing data from
the Growing Up in Singapore Towards Healthy Outcomes (GUSTO) project, an ongoing prospective study in
which many of the same, or comparable, measures that we administered in our project have also been
collected regularly from approximately 1,500 parents and children since the prenatal period. Extending and
replicating our findings with the GUSTO dataset, which includes younger, non-Western children from
Southeast Asian families in Singapore, will complement findings from other large cohorts, like ABCD and
NCANDA, that have assessed only Western participants. Finally, will leverage our own and GUSTO data to
examine the effects of the COVID-19 pandemic shutdown on children’s and adolescents’ psychobiological
functioning. In both datasets we have a unique opportunity to compare comprehensive psychobiological data
collected from the same youth before and after the pandemic shutdowns in order not only to examine how the
pandemic has altered young people’s psychobiological functioning and development, but importantly, to also
identify risk and resilience factors across cultural contexts. Further, the new proposed adult assessment in our
ELS project will allow us to examine the persistence of COVID-related difficulties by re-assessing participants
whom we studied soon after pandemic quarantine restrictions ended.

Public health relevance
Project Narrative/Public Health Relevance: Early life stress (ELS) is a significant risk factor for the development of psychopathology from childhood to young adulthood; in this project we will augment our existing rich longitudinal dataset by conducting an additional assessment of our participants at age 20 to examine the effects of ELS on trajectories of neurodevelopment and clinical outcomes from childhood to young adulthood, as well as the persistence of COVID-19 pandemic-related difficulties in mental health, stress, and brain metrics. We will also extend and replicate our findings in a larger, younger, non-Western sample of youth, in whom we will also examine the effects of the COVID-19 pandemic on young people’s health. Findings from this project will inform efforts to generate personalized targets in order to tailor prevention and treatment programs for adolescents who are at high risk for the onset of depression, for other forms of psychopathology, and for engaging in suicidal behaviors.